Ethnic disparities in methotrexate neurotoxicity among children and adolescents with ALL

Project 2: Ethnic disparities in methotrexate neurotoxicity among children and adolescents with acute
lymphoblastic leukemia
Project Summary
Improvements in the treatment of childhood acute lymphoblastic leukemia (ALL), including the adoption of risk-
adapted, multi-agent chemotherapy, have resulted in five-year survival rates exceeding 85% in most developed
countries. The antifolate agent methotrexate (MTX) is a critical component of curative pediatric ALL protocols.
Approximately 10% of pediatric ALL patients experience acute or subacute neurotoxicity following intrathecal (IT)
or high-dose intravenous (IV) MTX. However, Latino children appear to experience MTX-associated neurotoxicity
more frequently. Further, the clinical management of MTX-related neurotoxicity often involves treatment delays
and/or modifications, which may limit anti-leukemic efficacy and impact survival. A number of factors likely
contribute to disparities in pediatric ALL neurotoxicity and related treatment outcomes, including clinical
characteristics, pharmacogenomics, disease features, and socioeconomic factors. Notably, racial and ethnic
disparities in pediatric ALL outcomes, including relapse, can be explained in part by underlying variation in
genetic ancestry, suggesting the frequency of variants involved in antileukemia therapy pharmacodynamics and
pharmacokinetics vary across ancestral populations. Our overall goal is to better understand the factors
contributing to disparities in treatment-related toxicities and treatment outcomes among Latino children with ALL.
Our overarching hypothesis is that underlying germline genetics, tumor biology, and social determinants of health
contribute to poorer outcomes in this vulnerable population of children. To address our goal, we propose the
three specific aims. Aim 1: Compare the impact of acute MTX neurotoxicity on clinical treatment course and
outcomes (e.g., relapse) between Latino and non-Latino White patients with ALL. Aim 2: Identify clinical,
socioeconomic, pharmacogenomic, and metabolomic predictors of initial MTX neurotoxicity and neurotoxicity
recurrence following MTX re-challenge, while accounting for the impact of ethnicity. Aim 3: Identify alterations in
white matter integrity associated with initial MTX neurotoxicity and neurotoxicity recurrence following MTX re-
challenge using standard and novel imaging techniques, in the context of ethnic variation. This project will provide
insights into the factors responsible for increased neurotoxicity in Latino children with ALL and may identify
pharmacogenomic and imaging features of at-risk individuals that allow prevention of initial or subsequent events,
and improvement of ALL outcomes.

Public health relevance
Project 2: Ethnic disparities in methotrexate neurotoxicity among children and adolescents with acute lymphoblastic leukemia Narrative The antifolate agent methotrexate (MTX) is a critical component of curative pediatric acute lymphoblastic leukemia (ALL) protocols. However, 10-15% of pediatric ALL patients experience acute neurotoxicity following intrathecal or high-dose intravenous MTX, with Latino children and adolescents experiencing a 2.5-fold increased risk of MTX neurotoxicity compared to non-Latino Whites. This project will provide insights into the factors responsible for increased neurotoxicity in Latino children and adolescents with ALL and may identify pharmacogenomic and imaging features of at-risk individuals that allow prevention of initial or subsequent events, and improvement of ALL outcomes.